Iowa CBDRP: Component A BD-STEPS II Core

PROJECT SUMMARY
In the US, major birth defects affect a delivery every 4½ minutes and the morbidity and mortality of tens of
thousands of children annually. An environmental (i.e. non-inherited) exposure or causal gene variant is
estimated to explain about one-third of all defects that occur. Since 1996, the Iowa Center for Birth Defects
Research and Prevention (CBDRP) has played a leadership role in surveillance and research of major birth
defects. Our partnerships with the Iowa Department of Public Health and Iowa Registry for Congenital and
Inherited Disorders provide comprehensive and timely surveillance of deliveries to Iowa residents. With these
partnerships, we successfully enrolled mothers in the National Birth Defects Prevention Study (NBDPS) and
Birth Defects Study To Evaluate Pregnancy exposureS (BD-STEPS) I. Using exposure data and biologic
specimens collected, we made substantial contributions to birth defects epidemiology, ranging from methods
development to identifying gene-environment interaction effects. Our work has provided critical insights into
birth defect etiology and been disseminated in high-impact journals. We propose to expand the work of the
Iowa CBDRP through successful participation in the BD-STEPS II. Our overall goal is to identify modifiable
maternal exposures in early pregnancy, which may increase the risk for having a pregnancy affected with a
major birth defect. We will expertly conduct comprehensive and timely data collection and reporting for the BD-
STEPS II using our highly experienced surveillance and research infrastructures. Our proposed research
approach is not only consistent with the BD-STEPS II required activities, but expands and innovates the
conceived study design (RFA-DD-18-001). We propose to address critical barriers identified in a recent review
of the NBDPS to investigate modifiable risk factors for major birth defects. To accomplish this, we will expand
the traditional epidemiology approach (used in the NBDPS and BD-STEPS) by integrating a multiomics
systems epidemiology approach. Our systems approach is novel in its application to NBDPS and BD-STEPS
data. It will use state of the art genomic analysis to lead to improved characterization of the case phenome and
improved delineation of pathways that influence birth defect development via the exposome. The expertise of
our key personnel and collaborating investigators, along with access to rich exposure and biologic data from
independent populations, provides us with unique resources among all CBDRPs, allowing us to successfully
implement our systems approach. Additionally, we will continue our leadership role and expand our training of
a future generation of birth defect researchers. Along with continuing to train pre-doctoral and postdoctoral
scholars, we will now include bachelor’s scholars. Our key personnel, investigators, and scholars will continue
our high productivity in disseminating findings from NBDPS and BD-STEPS through peer-reviewed
publications. Research findings generated will provide critical insights into modifiable risk factors for major birth
defects and be used for family education, treatment improvements, and application of prevention strategies.

Public health relevance
Project Narrative The Iowa Center for Birth Defects Research and Prevention, in collaboration with premier scientists nationally and internationally, will extend and expand its leadership role in the investigation of environmental exposures and genes for major birth defects. Our research will provide important insights into our understanding of modifiable factors to prevent or reduce the adverse consequences of major birth defects. Findings will be shared with other scientists, healthcare providers, policymakers, and families with the goal to develop appropriate prevention interventions and resources for families affected by major birth defects.